Association of Tau and Neuronal Hypometabolism with Positron Emission Tomography in Alzheimer's Disease

PROJECT SUMMARY
The National Institute on Aging and Alzheimer’s Association recently proposed the ATN framework to
systematically classify Alzheimer Disease (AD) in research studies and integrate standardized biomarkers with
clinical assessment. The framework is based on binary designations of the presence or absence of amyloid (A),
tau (T) and neurodegenerative (N) pathology, wherein AD is defined as A+/T+/N±. This biomarker discretization
may simplify AD diagnosis and management but does not enable a more quantitative dissociation of T and N
beyond the statement of T+/N±.
We are interested in studying neuronal responses to T pathology, including susceptibility (T<N) and resilience
(T>N). N has been defined to include structural volume loss (NS) on magnetic resonance imaging (MRI) and
lower neuronal metabolism (NM) on positron emission tomography (PET) with 18F-fluorodeoxyglucose (FDG).
There has not been substantial investigation comparing T with NM, which may necessitate a more nuanced,
comparison beyond the binary descriptions.
Here, we will utilize the AD Neuroimaging Initiative (ADNI) to investigate the match and mismatch of concomitant
T and NM with 18F-flortaucipir and FDG PET. We aim to (1) define “T/NM mismatch” measures derived from
several methods including region-of-interest clustering, voxelwise thresholding and deep learning, (2) evaluate
the relationships between T/NM mismatch with clinical factors (including cross-sectional and longitudinal
cognition, prognosis and progression of T pathology) and (3) assess relationships between T/NM mismatch
additional measures of N (including structural NS).
Whether in the presence or absence of disease-modifying AD therapy, our in vivo molecular neuroimaging
strategy may empower a more comprehensive understanding of the localization and sequence of pathological
events leading to AD and unique biological responses to T, including functional resilience.

Public health relevance
PROJECT NARRATIVE The ATN framework from the National Institute on Aging and Alzheimer’s Association discretizes biomarker levels of amyloid (A) and tau (T) and neurodegeneration (N) and defines Alzheimer Disease (AD) as A+/T+/N±, though a more granular approach could further probe the dissociation of T and N. Here, we will propose and implement machine learning approaches to construct T/NM mismatch measures between T and neuronal hypometabolism (NM) via tau and 18F-fluorodeoxyglucose (FDG) positron emission tomography (PET) and evaluate T/NM mismatch relationships with cognition and additional measures of disease. This study has the potential to illuminate heterogeneous spatiotemporal patterns of functional susceptibility and resilience to AD pathology and the proposed training will build my image analysis skills as an aspiring physician-neuroscientist.